Trunk control after human spinal cord injury

Abstract
Walking recovery is a top rehabilitation goal for many individuals with incomplete spinal cord injury (ISCI).
Accordingly, there are extensive resources invested into understanding ISCI-induced walking impairments and
developing interventions to advance recovery. While these efforts target lower extremity control, functional
walking is a full-body activity requiring rhythmic, coordinated movements of the limbs and trunk. After ISCI,
individuals often demonstrate trunk control deficits: aberrant trunk movements during stepping, impaired posture,
and consequently, reliance on assistive devices and ongoing walking impairment. Despite the importance of the
trunk in walking control, it is rarely an intervention target and clinical assessments of walking do not consider
trunk control. Instead, trunk control is assessed in sitting or static standing, which provides limited insight into
control during walking. Understanding of trunk control is critical to address the severe and persistent impairments
that limit walking function. Our long-term objective is to quantify trunk control during walking to inform critical
next steps in clinical assessment and future walking research. This initial study will quantify coordination of trunk
movements and underlying muscle activation. We will address following aims: Aim 1: To test the hypothesis
that individuals with ISCI demonstrate impaired coordination of trunk movements during walking. We
predict individuals with ISCI will demonstrate reduced counter-rotational trunk movement across the gait cycle.
The primary outcome will be the phase relationship between movements of the thorax and lower extremities,
quantified by continuous relative Fourier phase, an established approach to quantify phase relationships during
cyclic activities. Additionally, trunk kinematics (i.e., range of motion, accelerations) in all planes will be quantified
and differences between those with ISCI and controls will be calculated. Aim 2: To test the hypothesis that
individuals with ISCI demonstrate impaired intermuscular coordination of trunk and lower extremity
muscles during walking. We predict that individuals with ISCI will demonstrate a reduced number of co-active
muscle patterns to achieve the biomechanical sub-tasks of walking (i.e., limb loading, swing initiation). The
primary outcome will be the number of motor modules (i.e., groups of consistently co-activated muscles) required
to account for activation of 32 trunk and lower extremity muscles during walking. Additionally, timing of module
activation and relative muscle contributions will be quantified. Achievement of these aims will address a critical
gap in understanding walking control after ISCI. This 2-year study will provide initial evidence to develop larger,
more definitive investigations of trunk control during walking, a critical step for advancement of research and
care for people with ISCI.

Public health relevance
Project Narrative For many individuals with incomplete spinal cord injury, walking recovery is a primary goal. While functional walking requires trunk control and stepping, rehabilitation emphasizes stepping and overlooks trunk control, leaving individuals with severe trunk control impairments that increase fall risk and cause reliance on assistive devices. The proposed project will quantify neuromechanical control of the trunk during walking and provide a foundation to address this critical component of walking function after incomplete spinal cord injury.